Protective Host Immunity Against Pulmonary Cryptococcosis

DESCRIPTION: Cryptococcus neoformans infections are a significant cause of morbidity and mortality among AIDS patients. Global estimates suggest that one million cases of cryptococcal meningitis occur each year resulting in over 625,000 deaths. Because host immune responses are so vital to the control of cryptococcosis, the overall objective of our laboratory is to determine the mechanism(s) necessary to elicit protective immunity against C. neoformans infections. To this end, the studies conducted during the previous funding period employed a C. neoformans strain engineered to express interferon (IFN)-γ, designated H99γ?, to define protective immune responses against C. neoformans in mice. Importantly, we established for the first time that protective immunity against pulmonary cryptococcosis can be generated in T cell deficient hosts, thus providing proof of concept that vaccines targeting C. neoformans can elicit protection against cryptococcosis in immunocompromised patients. Additionally, preliminary results included herein show that signal transducer and activator of transcription 1 (STAT)-mediated classical macrophage (Mφ) activation is essential for the development of protective immunity against pulmonary cryptococcosis. Moreover, Mφs isolated from protectively immunized mice several weeks post-immunization have enhanced pro-inflammatory responses against C. neoformans that are associated with changes in their epigenetic programming. These exciting results support a novel paradigm for trained innate immunity against fungal pathogens. Altogether, our studies lead us to hypothesize that STAT1 signaling in Mφs is essential for classical Mφ activation and the induction of vaccine-mediated immunity against pulmonary C. neoformans infection. We plan to test our hypothesis and accomplish our overall objective by pursuing the following Specific Aims: (1) define the role of STAT1 signaling in the initiation of classical Mφ activation and antimicrobial activity against C. neoformans, (2 determine the mechanism(s) that facilitates STAT1-mediated classical Mφ activation and protection following immunization with C. neoformans strain H99γ, and (3) identify the epigenetic changes within Mφs of protectively immunized mice that are associated with protective immunity against C. neoformans.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cryptococcus neoformans is an opportunistic fungal pathogen that causes life-threatening infections in immune compromised individuals including AIDS patients. The studies proposed in this application are designed to determine a mechanism for inducing protective immunity against C. neoformans infections. My expectation is that these studies will lead to the development of immune-based therapies and/or vaccines to treat or prevent cryptococcosis.